Coordination Section

ABSTRACT
The BCM Center for Precision Medicine Modeling will support local, national, and international programs and
individual researchers in the development of precision animal models that (1) end the diagnostic odyssey of
patients with undiagnosed, rare, and Mendelian diseases and (2) serve as resources for pre-clinical studies
investigating personalized medicine approaches to their care. The Coordination Section led by the Center multi-
PI group and overseen by the Center Steering Committee, will harmonize the workflows within and between the
Center’s sections and units and enact tools and metrics to monitor Center progress and impact on biomedical
research. The Coordination Section will be responsible for maintaining internal and external Center
communications by scheduling meetings of section/unit working groups, all center staff, and the Center Steering
Committee. These meetings will be used to review section/unit operations, track project and milestone progress,
and select nominated variants for modeling. The Coordination Section will organize External Advisory Board
(EAB) site visits and will be responsible for implementing corrective measures identified by the EAB. To
streamline operations, the Coordination Section will work with each Section and Unit to establish Standard
Operating Procedures during the first year. Finally, the Coordination section will work with the Bioinformatics and
Resources and Services Sections to implement a communication and outreach strategy to recruit community-
based nominations of human allele variants.